Co-occurring factors that heighten transgender women's vulnerability to suboptimal ART adherence in India

SUMMARY
Background: In India, HIV prevalence is highest among transgender women (TGW) or Hijras. Although HIV can
be managed with ongoing antiretroviral therapy (ART), achieving maximal benefit necessitates engagement with
the healthcare system and requires excellent adherence, which has shown to be challenging in India despite
ART being free. Studies have shown that TGW in India experience high rates of individual (e.g., drug and alcohol
use, depression), interpersonal (e.g., victimization, discrimination), and structural (e.g., poverty, housing
instability, clinic access) challenges. While limited evidence suggests that these co-occurring syndemic factors
are associated with suboptimal adherence and viral suppression among TGW in other settings, little is known
about whether and how these factors influence ART adherence and viral suppression among TGW in India.
Moreover, while TGW experience high rates of discrimination and familial rejection based on their gender
identity, which may be compounded for TGW living with HIV, many TGW in India counteract this familial and
societal rejection by forming their own family units comprised of other TGW. Based on research in other settings,
this social support might buffer the detrimental effect syndemic factors may have on ART adherence.
Environment: We will leverage an established, 16-year research collaboration between the PI’s mentors and
Humsafar Trust (HST), the largest NGO focused on sexual and gender minority health in India – with research
sites in both Mumbai and New Delhi, India's two biggest cities with 12.5 and 16.8 million people,
respectively. Approach: The study aims to understand patterns and high-risk groups underlying suboptimal ART
adherence and unsuppressed viral load related to substance use, stigma, and other syndemic factors among
TGW in Mumbai and New Delhi, India and to assess potential buffering mechanisms for future intervention
targets. To this end, we propose to: (1) conduct qualitative interviews with TGW (n=30) and clinical and social
service providers (n=10) to assess the individual, interpersonal and structural level syndemic factors impacting
ART adherence and unsuppressed viral load; and (2) to characterize patterns of multilevel syndemic factors and
identify high-risk profiles of 150 TGW living with HIV in Mumbai and New Delhi. We will conduct a quantitative
assessment and use Latent Class Analysis (LCA) to determine the patterns of the multilevel barriers that arise
in Aim 1, and fit a multilevel model to better understand the relationships between the identified syndemic classes
and unsuppressed viral load (via plasma viral load testing) and ART adherence (via self-report). Findings from
this R36 doctoral dissertation award will provide preliminary data, using qualitative and LCA syndemic risk
profiles, to support the submission of a larger NIH grant to design and pilot test an adaptive, multi-component
(e.g., possibly including substance use treatment, resilience coping, skill-building) intervention to improve HIV
care continuum outcomes among TGW living with HIV in India.

Public health relevance
NARRATIVE Transgender women living with HIV face unique individual, interpersonal, structural level barriers to optimal HIV care outcomes (e.g., substance use, stigma, and poverty) in India. The current research study proposes to examine how substance use, stigma, and other syndemic barriers impact ART adherence and viral suppression and if social support serves as a buffer. The study will provide data to inform culturally appropriate, effective interventions to improve HIV care continuum outcomes in this group.